Modeling Environmental Impacts on Bronchiolitis in the Presence of Spatial Uncertainty

? DESCRIPTION (provided by applicant): This research project develops scalable statistical models that (i) account for spatial uncertainty in various types of data and (ii) integrate many different databases collected at various space-time scales into a comprehensive analysis of bronchiolitis. This re- search is primarily motivated by health information on bronchiolitis from the US Military Health System (MHS). The MHS bronchiolitis database contains more than 140,000 bronchiolitis cases that have been spatially and temporally randomized (jittered) to ensure privacy. Hence, to properly utilize the MHS database to understand environmental factors influencing bronchiolitis abundance requires statistical methods that (i) account for the types of spatial uncertainty in the MHS data and (ii) combine multiple types of spatial data (e.g. air pollution and census data) on a large space-time scale.

Public health relevance
PUBLIC HEALTH RELEVANCE: Data used to study the spread of bronchiolitis commonly record approximate spatial locations rather than exact locations. This project seeks to combine multiple types of health data to study the spread of bronchiolitis when the recording of spatial locations in done imprecisely (either by error or to ensure privacy). Ultimately, this research supports efforts to develop better strategies for preventing the spread of bronchiolitis.